BLRD Research Career Scientist Award Application

Project Summary:
Dr. Rhoades (formerly Sterling) is currently funded by a VA Merit award entitled “Reprograming tumor
associated macrophages to induce anti-tumor immune responses in bone metastatic breast cancer.” She
began in the VA in 2010 with a CDA and has maintained VA Merit funding since 2013. Her work seeks to
identify novel therapeutic strategies to reduce tumor induced bone destruction from tumors that
frequently spread to the bone. Once established these tumors disrupt normal bone remodeling leading
to increased fractures and bone complications. Unfortunately, Veterans experience higher rates of
invasive and metastatic tumors and reduced survival. They also have higher rates of bone diseases (from
trauma, exposure, and other diseases) which can further complicate therapeutic intervention. Dr.
Rhoades is a leader in the cancer and bone field and has dedicated her career to understanding
interactions between tumors, bone, bone marrow and cancer therapies. Her goal is to identify novel
approaches that can improve diagnosis, outcome predictions, and therapies that will ultimately improve
Veteran quality of life and disease-free survival. Through this work, Dr. Rhoades has been funded by the
DOD, NIH, and non-profit funding sources and has published her work regularly in well-respected bone
and cancer journals. In addition, she is president of the Cancer and Bone Society, a co-editor-in-chief of
the Journal of Bone Oncology and actively participates in cancer and bone meetings and societies.

Public health relevance
Project Narrative: Dr. Rhoades is an active VA investigator whose work seeks to identify novel therapeutic approaches to treating cancer induced bone diseases. Her current projects seek to target novel interactions between bone marrow macrophages and tumor cells using immune therapies in combination with tumor targeted therapies to reduce tumor growth, bone destruction, and bone marrow complications. These studies will impact Veteran populations, which have higher rates of invasive and metastatic tumors and lower survival rates, by identifying effective and less toxic therapies for patients with bone metastatic tumors including breast, head and neck cancer, and prostate cancer (which all impact Veteran disproportionately).